International Research Training Center for Botanicals and Chronic Diseases (CBCD) in Tajikistan and Indonesia

Summary
Our research training programs in Tajikistan and Indonesia have evolved into a well-developed,
comprehensive, and thoroughly vetted research training curriculum partially based on the online
learning platforms. Our successes and international visibility led to multiple inquiries from
colleagues in other countries about joining our training Center for Botanicals and Chronic
Diseases (CBCD). Specifically, our long-term Ecuadorian colleagues working in two major
universities in Quito (Universidad San Francisco de Quito and Universidad Internacional del
Ecuador) asked about joining CBCD through the administrative supplement mechanism. We
feel that our extensive research training network and well-tested learning platforms allow
smooth inclusion of an additional country into the program, regardless of its geographical
location. Our year-long accelerated research training program in Ecuador will focus on the
following three aims:
 Recruit and train 8 Master level trainees in two leading Ecuadorian Universities: Universidad
San Francisco de Quito and Universidad Internacional del Ecuador for an accelerated one-
year research training program. The trainees will be recruited by December 2023 and
graduate in December 2024.
 Fully integrate Ecuadorian trainees into the existing online training curriculum, as well as
mentorship and research peer programs with faculty, postdocs and graduate students at
Rutgers and CUNY. Include Ecuadorian students in planned scientific seminars and Zoom-
based symposiums and encourage their interactions with our trainees in Tajikistan and
Indonesia. This relationship will continue beyond one year with no additional cost to the
CBCD.
 Conduct one in-person research symposium in Ecuador with electronic participation of Tajik
and Indonesian trainees.

Public health relevance
Narrative This supplement will extend our successful international research training program to Ecuador, where we have an established collaborative network in two major universities. Our aim is to provide a sustainable foundation for research and retention of Ecuadorian scientists in the interdisciplinary studies of botanicals for the prevention and treatment of chronic diseases.